Addressing Colorectal Cancer-Related Distress: Developing and Evaluating a Couple-Based Mindfulness Intervention

PROJECT SUMMARY/ABSTRACT
A diagnosis of metastatic colorectal cancer (mCRC) and its treatment is life-altering; up to 60% of mCRC patients
and a similar percentage of their intimate partners report clinically significant levels of distress.1-5 Effects of
mCRC often lead to unique challenges on both an individual and relationship level,6-14 and an intervention
designed to address these concerns and reduce distress in couples facing mCRC is critically needed.6-8,10-12,28,30
A mindfulness-based intervention (MBI) could fill this gap, given strong evidence for reducing distress in cancer
patients32-34 and partners35 and in improving relationship outcomes.36-38 However, existing MBIs are poorly suited
for couples facing mCRC due to several inadequacies in their content and format. Given significant changes that
would be needed to modify an existing MBI, a new couple-based MBI designed to meet the unique needs of
mCRC couples is warranted. Therefore, the overall objective of the proposed research project is to develop,
refine, and evaluate a four-session, couple-based mindfulness intervention (“MIND-Together”: Mindfully
Navigating Distress Together) delivered via video-conference and designed to promote mindful coping and
reduce distress for mCRC patients and their partners. First, we will generate data on the needs and preferences
of 12 couples facing mCRC (N=24 patients and partners) and 12 clinicians treating mCRC through qualitative
interviews, which will include queries about intervention content (e.g., scope) and structure (e.g., format). Then
we will develop drafts of the intervention protocol, which will be refined and finalized through cognitive interviews
with 6 mCRC couples (N=12 patients and partners) and expert review. Second, we will assess the feasibility,
acceptability, and preliminary effects of the intervention through a pilot randomized controlled trial among 45
mCRC couples (N=90 patients and partners), assigned 2:1 to either MIND-Together (n=30 couples) or an
attention-controlled condition (n=15 couples). In an exploratory aim, we will use exit interviews to explore
couples’ experiences of MIND-Together in order to further optimize the intervention content and delivery, and
identify potential mechanisms to assess in future trials. Upon study completion, we will have established whether
the intervention is feasible, acceptable, and preliminarily efficacious in reducing distress in a sample of couples
facing mCRC. Future research will be to evaluate the intervention efficacy and assess mediators in a larger
randomized trial. In addition to the research study, formal training in three content areas will support the PI’s goal
of becoming an independent investigator with expertise in the development, evaluation, and delivery of
interventions among individuals affected by cancer. Training areas include: (1) cancer survivorship issues among
colorectal cancer patients, (2) couple-based approaches for improving psychosocial outcomes in cancer
survivors, and (3) developing and evaluating psychosocial interventions. Overall, the proposed research has the
potential to help address the critical psychosocial needs of couples facing mCRC and to advance the science of
mindfulness and couple-based approaches in cancer care.

Public health relevance
PROJECT NARRATIVE Coping with metastatic colorectal cancer (mCRC) is a highly distressing experience for patients as well as their partners. Clinical interventions that offer brief, accessible, and effective coping tools to both members of the couple may significantly improve the quality of life of both patient and partner, thus addressing an important gap in current clinical care. The proposed research offers to fill this gap by developing and piloting a brief, couple- based mindfulness intervention aimed to reduce distress and improve the quality of life of patients with mCRC as well as their partners.